SWG1: HIV/TB Scientific Working Group

Project Summary/Abstract
The Providence/Boston (P/B) CFAR's HIV-TB Scientific Working Group (SWG) was established in
January 2017, and has built on the complementary scientific expertise of the Brown/Lifespan and BUMC HIV
and tuberculosis (TB) research groups, and their domestic and international sites, in order to understand the
bidirectional effects of HIV and TB and their respective global epidemics. Currently, research on TB and HIV/TB
accounts for a major component of the funded research base (FRB) of the P/B CFAR. There are unique
opportunities for the P/B CFAR HIV-TB SWG to develop innovative research in three areas: first, to refocus
research on TB to incorporate HIV/TB, addressing issues pertaining to the natural history of HIV and its
pathogenesis; second, to introduce biologic components to research that is at this point primarily clinical and/or
behavioral; and third, to attract junior and senior researchers to the field. The P/B CFAR has committed to take
advantage of these opportunities by creating this HIV-TB SWG.
The SWG will bring together investigators currently working on HIV/TB issues with those not currently
involved in this research to share ideas and identify potential sub-studies within their currently funded projects,
as well as potential new projects. This will be done via bi-monthly lunch meetings, alternating between Brown
and BU, annual CFAR sponsored TB meetings, and the SWG Executive Committee will meet semiannually to
review participation in these activities and assess whether they are leading to the desired outcomes and outputs.
In addition, the SWG will add to the productivity of the other P/B CFAR Cores by applying their expertise to
addressing the SWG Specific Aims. Thus, the SWG will add value both by facilitating the development of new
and innovative projects as well as by maximizing the productivity of the CFAR Cores.